Achieving Optimal Sexual and Reproductive Health (SRWH Project)

My Brother’s Keeper, Inc., and it partners, the University of Mississippi Medical Center, the University of Southern Mississippi, and the Mississippi State Department of Health, propose to implement the Achieving Optimal Sexual and Reproductive Health (SRWH) Project Among Racial/Ethnic and Sexual/Gender Minorities in Mississippi. The SRWH Project will be designed to address the reproduced healthcare needs adults of reproductive age (18 to 45 years old) who identify as racial/ethnic and sexual/gender minorities in the largely rural state of Mississippi. The project aims to end racialized prioritization of need in the state, and as such, uses more complex markers of social vulnerability to identify priority areas in the state where racial/ethnic and sexual/gender minorities are more vulnerable based on comprehensive social and maternal vulnerability indices. Our approach, a community-based participatory approach, ensures that the very lives we aim to improve have the leading voice in prioritizing the structural factors that need to be addressed and the health outcomes that need to be measured. The proposed project will potentially address key structural factors related to the availability of non-discriminatory healthcare services and resources. We will address two core areas including promoting uninterrupted healthcare utilization and adherence as well as expanding broadband infrastructure to increase healthcare access. Access to safe, non-discriminatory care is a key initial step to address reproductive and sexual health priorities, including maternal health and HIV/STD incidence, in Mississippi.